Probing the flexibility of G0

Project Summary/Abstract
The cell cycle is an ordered series of molecular events in a cell leading to division and production of two
daughter cells. This process is fundamental to the development of all multicellular organisms, which begin from
a single cell, the fertilized egg. Equally important for proper development though, is the slowing or stopping of
the cell cycle at the right places and times as cells, tissues and organs mature. In fact, the majority of cells in
multicellular organisms spend most of their existence in non-proliferating states, often referred to as cellular
quiescence or the G0 phase. In their non-dividing state, quiescent cells are metabolically active and carry out
critical physiological functions in tissues and organs. Despite the importance of G0, most studies of cell cycle
regulation have focused on rapidly dividing cells. Thus, it remains unclear how cells choose to enter G0 during
development, and why some cells can choose to leave G0 and later re-enter the cell cycle in response to
developmental signals, tissue damage, or nutrient availability while others cannot. It has become clear that
there are multiple states of G0, some that are readily reversible, and others that are permanent. Different
states of states may be controlled in distinct ways, both in the manner of cell cycle inhibition and in the
pathways used to initiate exit. The goal of the work described here is to understand how the cell cycle
machinery is controlled during the decision to exit the cell cycle, and how G0 can be modulated to be
more or less reversible in different contexts. This work impacts a wide range of biological questions, as the
proper control of quiescence is critical in development and tissue regeneration, but becomes disrupted in aging
and cancer.

Public health relevance
Project Narrative Most cells in adult animals are in a non-cycling, quiescent state often referred to as G0. Some cells enter reversible states of G0 while others enter more robust and permanent states of G0, but the differences between reversible G0 and permanent G0 are poorly understood. This work investigates the molecular mechanisms that control different states of G0 across tissues, with an ultimate goal of generating tools to manipulate and control G0, which becomes improperly regulated in both cancer and aging.